Colorado Center for Diabetes Translation Research (CO-CDTR)

Center Overview: Project Summary
American Indians and Alaska Natives (AI/ANs) are at substantial risk of diabetes. They exhibit rates of diabetes
often greater than other citizens; they suffer serious, debilitating complications thereof; a disproportionate share
of their scarce health care resources are consumed by a small percentage of patients with diabetes. A growing
body of knowledge about evidence-based policies, programs and practices promises to redress these disparities.
The Center for American Indian and Alaska Native Diabetes Translation Research: 1) Provides an administrative
structure that promotes diabetes-related translational research capacity. Its Pilot and Feasibility Program
supports small-scale, innovative projects; 2) Offers related training, technical assistance, and consultation to
investigators and key stakeholders through an Enrichment Program; 2) Sustains and expands a Research Base
of funded faculty whose research either directly targets diabetes prevention and treatment or is translational in
nature with clear potential for application to diabetes translational research; 3) Supports a Translational Research
Core that offers resources in the cultural adaptation of interventions, health literacy, health technologies,
dissemination and implementation science, cost of care/ sustainability, and qualitative research methods to
advance a culturally grounded, multidisciplinary problem-oriented translational research program of major
scientific and programmatic importance to Native people; 4) Serves as a National Resource Core for other
investigators and programs pursuing diabetes translational research with AI/AN communities; and 5) Establishes
a Community Outreach and Engagement Core that promotes the dissemination of lessons learned and ensures
key stakeholder participation in their extension to this special population.

Public health relevance
Center Overview: Project Narrative American Indians and Alaska Natives (AI/ANs) exhibit high rates of diabetes and serious, debilitating comorbidities, the treatment of which consumes a large share of increasingly scarce health care resources. This Center promotes research and builds capacity that promises to redress these disparities.